THERAPY FOR GESTATIONAL DIABETES WITH FASTING HYPERGLYCEMIA

The main objective of this project is to optimize metabolic management of gestational diabetes (GDM). Investigators will test the hypothesis that fetal ultrasound between 29-33 weeks gestation can discriminate between the subset of those patients who can benefit from insulin therapy, and the subset who require only dietary treatment.